Biased sweet taste signaling pathways in mice and humans

The obesity epidemic has reached alarming proportions in many parts of the world, fueled by the over
consumption of calorie-rich foods, primarily sugars in the form of sugar-sweetened beverages and other
sweet foods. Hence, novel strategies are needed to prevent excessive sugar consumption and to promote
a healthy diet. Non-caloric sweeteners have been used for several decades to replace sugar-derived
calories. However, their health benefits have been questioned and their taste profile is inferior to sugars.
Therefore, there is a need to develop novel healthy and tasty non-caloric sweeteners. The sweet taste
receptor - a heterodimeric G-protein coupled receptor (GPCR) formed by the TAS1R2 and TAS1R3
subunits - is the primary receptor for sugars and non-caloric sweeteners. Studies to date have focused on
the G-protein mediated pathway as the primary mechanism for transduction of sweet taste signaling
downstream of the sweet taste receptor. However, it is now well known that the arrestins, adaptor proteins
first identified as mediators of GPCR- desensitization, can transduce signals down stream of GPCRs on
their own. The G-protein and arrestin pathways engage different downstream signaling partners and
consequently, have different physiological effects. An exciting development in pharmacology is the
discovery that some GPCR ligands differentially engage the G-protein and arrestin pathways, although they
bind to the same receptor. Such biased ligands are exciting drug candidates. Using single-cell RNASeq, we
showed that Arrb1 is the sole arrestin expressed in sweet taste receptor expressing cells. We propose to
identify the role of arrestin signaling in sweet taste using conditional knockout (CKO) mice models and
taste organoids cultured from this strain. We will confirm the specific expression of Arrb1 in sweet taste
cells using in situ hybridization and immunohistochemistry and will compare the behavioral and taste nerve
responses of Arrb1CKO and control mice to sweet and other control taste stimuli. The kinetics of arrestin
binding to the sweet taste receptor, sweet taste adaptation, and arrestin signaling will be studied in taste
organoids using microscopic and other assays (Specific Aim 1). Unfortunately, such mechanistic studies
are not possible in humans, as human taste stem cells have not been identified. We will use cutting-edge
spatial transcriptomics of human and mouse taste papillae and compare this to existing droplet-based
scRNASeq data from mouse cells, to identify human taste cell types including stem cells and the growth
factors required for regeneration of taste cells (Specific Aim 2). Data from this study will enable the
development of tools and strategies to manipulate sweet taste signaling.

Public health relevance
The overconsumption of sugars is one of the major drivers of the obesity epidemic. Currently used noncaloric sweeteners are not ideal substitutes for sugars. We will study the role of the arrestin signaling pathway in sweet taste with the goal of targeting it to develop novel healthy noncaloric sweeteners, and apply newly developed spatial transcriptomics methods to study human and mouse taste papillae to gain a better understanding of these tissues